Clinical Protocol and Data Management

Clinical Protocol and Data Management Project Summary / Abstract Clinical Protocol and Data Management has five primary responsibilities: clinical research quality assurance; clinical research education; clinical research informatics; clinical research analytics; and inter-institutional clinical research operations coordination. The Unit helps ensure appropriate coordination, communication and consistency throughout the clinical trials platform by managing or participating in all DF/HCC clinical trials activities. The CPDM works closely with DF/HCC's protocol review office, which supports the PRMS, and other DF/HCC clinical trials cores, such as Research Pharmacy and Biostatistics. It also works with the clinical trials offices at member institutions to facilitate coordination, communication, standardization of processes and implementation of best practices.

Public health relevance
Project Narrative Not applicable.